University of Hawaii Cancer Center CCSG

ABSTRACT
The mission of the University of Hawai‘i Cancer Center (UHCC) is to reduce the burden of cancer through
research, education, patient care and community outreach with an emphasis on the unique ethnic, cultural and
environmental characteristics of Hawai‘i and the Pacific. To accomplish this mission, UHCC is organized into
two cancer research programs: Population Sciences in the Pacific (PSP) and Cancer Biology (CB).
Programs are each organized with two components spanning the study of basic mechanism and etiologies of
cancer to addressing targets and interventions in order to translate discovery to the population it serves. Within
its programs, UHCC has a strong foundation of cancer research with over $15 million in peer-reviewed funding,
72.5% of which is from the NCI. PSP has 28 full members and CB has 20 full members who are highly
collaborative as evidenced by a high percentage of intra- and inter-programmatic, and inter-institutional, research
collaborations and publications. To facilitate successful attainment of research goals, UHCC supports five
shared resources: Biostatistics, Genomics and Bioinformatics, Analytical Biochemistry, Nutrition
Support, and Metabolomics. UHCC serves a unique ethnically diverse catchment area in Hawai‘i and the
Pacific and a unique environment rich in natural resources. This drives UHCC’s focus on ethnic diversity and
cancer and research and community engagement directed toward addressing significant cancer health
disparities among specific populations, including Native Hawaiians. Research programs, community education,
public health and clinical trial interventions are targeted toward cancers of importance in the catchment area and
basic investigations include evaluation of compounds from the environment for drug discovery research. A
unique, community-network based clinical research enterprise has been established through which UHCC
provides access to cancer clinical trials for over 70% of the Hawai‘i population; this is supported in part by a
UHCC-led affiliation of three competing health systems as a cooperative venture supporting UHCC. Cancer
prevention activities across the Pacific, in collaboration with the University of Guam and others, have had major
impact on cancer control and have led to the formation of the UHCC-led Trans-Pacific Partnership for Cancer
Prevention. The importance of UHCC in the region is exemplified by its significant impact on cancer control
legislation and State cancer policy. The University of Hawai‘i (UH) has made significant investments in UHCC.
With the recruitment new Director, UH reaffirmed the Director’s direct authority over faculty appointments and
affairs, Center budget and operations, and space allocation in the 187,000 sq. ft. Cancer Center building. The
University, Governor and State have provided increased financial support for operations and authorized
numerous faculty recruitments to strengthen existing programs and embark on new initiatives informed through
the UHCC strategic planning process in support of its mission to reduce the burden of cancer.

Public health relevance
PROJECT NARRATIVE The mission of the University of Hawai‘i Cancer Center (UHCC) is to reduce the burden of cancer through research, education, patient care and community outreach with an emphasis on the unique ethnic, cultural and environmental characteristics of Hawai‘i and the Pacific. UHCC supports an infrastructure to translate basic, translational and population-based discovery to clinical and public health practice, facilitate access to novel cancer clinical, prevention and community trials, and engage the medical community, and the community at large, in order to advance the science and practice of cancer risk assessment, cancer prevention, cancer treatment, and cancer healthcare delivery.